Septhohippocamal connectome dysfunction in Down syndrome associated with Alzheimer’s disease pathophysiology

ABSTRACT
Down syndrome (DS) is caused by triplication of human chromosome 21 and results in physical and cognitive
developmental delay and disability. Individuals with DS transition to Alzheimer’s disease (AD) in early midlife
and develop premature dementia along with histopathological hallmarks of AD including amyloid-beta and tau
pathology, synaptic deficits, and neurodegeneration. This sequence of pathological hits preferentially impacts
vulnerable neural networks such as the septohippocampal and basocortical circuits which support attention,
memory, and executive function. While DS and AD phenotypes overlap in many respects, the extent of shared
cellular pathophysiological mechanisms remains poorly understood. The knowledge gap is a potentially missed
opportunity to arrest the onset of AD dementia in DS. We propose to identify molecular, cellular, and
physiological substrates underlying vulnerability of the septohippocampal and basocortical connectomes in
trisomic (Ts65Dn) mice, which faithfully reproduce circuits with memory and executive function deficits in
human DS and AD. In parallel, we will study human induced neurons (HiN) derived directly from DS, AD, and
control fibroblasts to reveal functional consequences of transcript-level alterations in human neurons. Our cell
and animal model findings will be validated in postmortem human brain. Specifically, we propose to identify
molecular and cellular substrates underlying calcium signaling and mitochondrial network dynamics within the
septohippocampal and basocortical connectomes in young {~4 months of age (MO), middle age (~12 MO) and
older (~18 MO)} Ts65Dn mice relative to normal disomic (2N) littermates and in HiN from DS, AD, and age-
matched controls. We will evaluate physiological and synaptic signaling properties of septohippocampal and
basocortical neurons in acute mouse brain slices and HiN. We will compare expression profiles from these
models to neurons obtained postmortem from individuals with DS, AD, and controls. In Aim 1 we will test the
hypothesis gene expression pathways regulating calcium handling, oxidative phosphorylation, and synaptic
signaling within basal forebrain cholinergic neurons (BFCNs) precede defects in hippocampal and frontal
cortical pyramidal neurons in trisomic mice. In Aim 2 we will test the hypothesis differential gene expression
pathways in DS manifest as progressive defects in synaptic and calcium signaling, mitochondrial dysfunction,
and protein mishandling in DS cell and animal models. In Aim 3 we will test the hypothesis dysregulated genes
and pathways in trisomic mice are significantly altered within HiN and analogous postmortem neuronal
populations in individuals with DS and AD. This multidisciplinary approach combining single population RNA-
sequencing with electrophysiological interrogation enables a determination of the pathobiology underlying
BFCN, CA1, and cortical neuron vulnerability in vivo in Ts65Dn and 2N littermates compared to HiN and
postmortem human DS neurons with co-occurring AD pathology. We posit these previously unavailable
findings will generate new therapeutic strategy approaches for DS and AD.

Public health relevance
NARRATIVE Down syndrome (DS) is the most common genetic cause of intellectual disability, and individuals with DS transition to Alzheimer’s disease (AD) by early midlife, developing premature dementia and pathological hallmarks of AD including amyloid-beta and tau pathology, synaptic deficits, and neurodegeneration of key circuits underlying memory, attention, and executive function including the septohippocampal and basocortical connectomes. We propose to define underlying mechanisms how DS-driven gene-level alterations in key neuronal networks regulating cognitive abilities impact function, and link DS to AD onset and/or progression through a multidisciplinary approach including single population RNA sequencing (RNA-seq) and electrophysiological studies using an established trisomic mouse model of DS and AD, human induced neurons (HiN) derived from DS, AD, and control fibroblasts, along with analogous profiling of septohippocampal and basocortical neurons from postmortem DS, AD, and age-matched nondemented control brains. Leveraging rigorous preliminary data, we hypothesize neuronal signaling dysfunction and mitochondrial/oxidative phosphorylation deficits, driven by gene and pathway level changes, underlie cognitive decline associated with memory, attention, and executive function failure in DS preceding the transition to AD.